Southwest Center for Agricultural Health, Injury Prevention, and Education

OVERALL
Project Summary
The Southwest Center for Agricultural Health, Injury Prevention, and Education (SW Ag Center) is a well-
established organization based at the University of Texas Health Science Center at Tyler. The SW Ag Center
will build on over 25 years of service in Public Health Region 6 (Arkansas, Louisiana, New Mexico, Oklahoma,
and Texas) through the proposed work. The mission of the SW Ag Center is to improve the safety and health
of agricultural, forestry and fishing (AgFF) workers. This is accomplished through an integrated program of
research, intervention, translation, surveillance, and outreach activities that engage and leverage a network of
strategic partners who represent the interests of a diverse worker population and a wide range of AgFF
production. The Center is positioned to expand its connections with industry segments, state departments of
agriculture, cooperative extension, trade associations, and service providers. The proposed scope of work is
responsive to the current funding announcement and is organized around the theme “Leveraging strategic
partnerships to advance best practices that promote and protect the health and safety of diverse AgFF
populations.” The SW Ag Center team consists of multidisciplinary faculty, staff, investigators, regional
advisors, and extension partners who are organized to foster cohesive, coordinated, and synergistic
operations. Proposed research includes two basic science projects led by experienced PIs. They will (1)
investigate the role of bacterial extracellular vesicles from organic dust in lung inflammation and (2)
characterize and compare worker health status on western US dairy farms. The SW Ag Center portfolio
includes three intervention projects aimed at different regional audiences: These projects address (1) health
disparities among commercial fishermen, (2) safety climate in grain handling facilities, and (3) safety
considerations for agricultural pilots and operators. The Center's translation project focuses on hearing
conservation for independent contract loggers and surveillance research will integrate motor vehicle crash and
injury data in AgFF sectors. The regional capacity for AgFF research will be strengthened through the Center's
pilot feasibility program. Outreach activities will develop pragmatic approaches to move research findings and
best practices into the workplace. Early-stage professionals will also be supported through outreach mini
grants, internships, practicum experiences and capstone projects. Research and outreach will be guided and
continuously improved by a cohesive and coordinated evaluation plan. The SW Ag Center is equipped with the
necessary experience and resources to identify practical solutions to persistent and emerging issues while
cultivating effective partnerships with diverse AgFF groups.

Public health relevance
OVERALL Project Narrative The region served by the Southwest Center for Agricultural Health, Injury Prevention, and Education (SW Ag Center) includes diverse agricultural, forestry and commercial fishing (AgFF) operations. In addition, workers themselves have different ages, genders, education levels, cultural backgrounds, health practices, vulnerabilities, and levels of access to information and healthcare. A qualified regional Center can coalesce resources and strategies to effectively address AgFF occupational safety and health through basic research, intervention science, translation efforts, surveillance, multimodal outreach activities, capacity building opportunities, emerging issues response, and an effective evaluation program.